A collaborative cross mouse model of Salmonella Typhi Chronic Carriage

PROJECT SUMMARY
Salmonellae are Enterobacteriaceae that cause a spectrum of disease in humans and animals, including enteric
(typhoid) fever and gastroenteritis. Typhoid fever, caused primarily by Salmonella enterica serovar Typhi (S.
Typhi), results in a life-threatening systemic disease that is responsible for significant morbidity and mortality
worldwide. Approximately 5% of individuals infected with S. Typhi become chronic carriers with the gallbladder
(GB) as the site of persistence, and these asymptomatic carriers represent a critical reservoir for further spread
of disease. We have demonstrated that gallstones (GSs) aid in the development and maintenance of GB carriage
in a mouse model (utilizing S. Typhimurium, which causes a typhoid-fever like disease in mice) and in humans,
serving as a substrate to which salmonellae attach and form a protective biofilm. Thus, biofilm formation is a key
step in the establishment of carriers. Until recently, typhoid fever has lacked a direct in vivo model, as S. Typhi
is host-restricted to humans. Recently, the Collaborative Cross project has produced a mouse strain (CC003)
that is permissive to S. Typhi infection, which we have utilized to create a model of chronic S. Typhi infection.
This model will be more physiologically relevant to human disease, as it will utilize the causative infectious agent
and not a closely related serovar. We hypothesize that the CC003 mice are permissive to S. Typhi chronic
infection through biofilm formation on gallstones and immune suppression. Further, we hypothesize that treating
chronically infected mice with our lead anti-biofilm agents will clear the carrier state. In Aim 1, we will determine
whether S. Typhi chronic infection is mediated by biofilm formation on cholesterol GSs and characterize the
inflammatory response within the GB of infected mice. Studies in Aim 2 will determine whether anti-biofilm
compounds in combination with antibiotics can clear the chronic carrier state of S. Typhi in the CC003 mouse
model. These experiments will develop a more physiologically relevant model of chronic typhoid fever and
characterize potential therapeutics.

Public health relevance
NARRATIVE Typhoid fever is an infectious disease caused by Salmonella Typhi (S. Typhi), a bacterium that causes as many as 20 million new infections and 600,000 deaths annually. Asymptomatic chronic carriers of S. Typhiplay a major role in the transmission of typhoid fever, as they intermittently shed the bacteria and can unknowingly infect others in their community. In this proposal, we will further develop and characterize a new mouse model of chronic S. Typhi infection, and utilizing this model, we will test the application of novel therapeutic compounds in clearance of chronic infections through disruption of the bacterial biofilm within the gallbladder.